Investigating Sex-Specific Hypothalamic Pathology and Immune Infiltration in Alzheimer's Disease

PROJECT SUMMARY
Nearly two-thirds of all Alzheimer’s disease (AD) cases are in females, suggesting sex differences in both
prevalence and presentation. Yet, the mechanisms underlying sex disparities in AD remain unknown. The
hypothalamus plays a key role in regulating numerous physiological processes that are disrupted in AD, such as
sleep-wake cycle, appetite, and sex-hormone production. The hypothalamus is also uniquely positioned as a hub
for peripheral signals in the brain due to its leaky blood-cerebrospinal fluid-barrier (BCSFB), central position in
the neuroendocrine axis, and bi-directional neuronal circuits. Recent evidence suggests tanycytes, specialized
ependymal cells that comprise the hypothalamic BCSFB, transport tau out of the cerebrospinal fluid (CSF) and
may be dysfunctional in AD. However, hypothalamic involvement and mechanisms of immune cell infiltration in
this region remain critically understudied in AD. Thus, interrogating the link between peripheral immune
infiltration and hypothalamic pathology is essential to understanding clinical symptoms underlying sex disparities
in AD. Preliminary data indicates uniquely altered populations of clonally expanded CD8 T cells exist in both the
blood and CSF of AD patients. Notably, these altered T cell populations could have increased access to the
hypothalamus due to the leaky BCSFB in AD patients. This led to the hypothesis that BCSFB dysfunction in the
hypothalamus results in increased peripheral immune infiltration and subsequent neuroinflammation in AD.
Therefore, the goals of this project are to investigate sex-specific transcriptomic alterations in the AD
hypothalamus (Aims 1 and 2) and explore how altered hormonal signaling may influence neuroinflammation in
the brain (Aim 3). Specific Aim 1 will utilize single-cell fixed RNA profiling to identify and evaluate cell-specific
transcriptomic alterations in AD hypothalamus, according to sex and disease severity. Specific Aim 2 will use
spatial transcriptomics to elucidate the spatial relationship between BCSFB dysfunction, neuroinflammation, and
AD pathology in the hypothalamus. Specific Aim 3 will use human induced pluripotent stem cells, phagocytosis
assays, flow cytometry, and qRT-PCR to delineate the effect of hormones on microglia. The proposed studies will
work towards establishing a mechanistic link between peripheral immunity and AD pathobiology in the
hypothalamus. They work to aid therapeutic approaches by providing deeper understanding about how BCSFB
function may exacerbate neuroinflammation and promote sex disparities in AD.

Public health relevance
PROJECT NARRATIVE The hypothalamus is responsible for maintaining many processes, such as sleep behavior, metabolism, and hormonal signaling, that are disrupted in Alzheimer’s disease. This project will investigate how hypothalamic pathology and neuroinflammation may contribute to underlying mechanisms of sex differences in AD. Understanding mechanisms of immune infiltration and neuroinflammation in the hypothalamus and how they may promote sex disparities in AD will inform the development of targeted therapeutics and enable better clinical interventions across the spectrum of AD severity.